Noncoding RNAs in Health and Disease

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Noncoding RNAs in Health and Disease, organized by Ramin Shiekhattar and Roberto Bonasio. The meeting will be held in Santa Fe, New Mexico from February 21-24, 2016. Over the past decade, there has been a greater understanding of genomic complexity in eukaryotes ushered in by the immense technological advances in high-throughput sequencing of DNA and its corresponding RNA transcripts. This has resulted in the realization that beyond protein-coding genes, there are a large number of transcripts that do not encode for proteins and, therefore, may perform their function through RNA sequences and/or through secondary and tertiary structural determinants. This meeting is focused on the latest findings concerning different classes of noncoding RNAs that use different strategies to regulate transcription. These are exciting times for discovering the biological scope and the mechanism of action for these RNA molecules, which have roles in dosage compensation, imprinting, enhancer function and transcriptional regulation, with a consequently great impact in development and disease. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting on Enhancer Malfunction in Cancer, which will share a keynote address and two plenary sessions with this meeting.

Public health relevance
PUBLIC HEALTH RELEVANCE: Given the potential key role of non-coding (nc)RNAs in orchestrating chromatin changes, it follows that a better understanding of their molecular mechanisms of action will directly benefit research on diseases with an epigenetic component. The Keystone Symposia meeting on Noncoding RNAs in Health and Disease will highlight major areas of ncRNA biology, progressing from molecular mechanisms in model organisms (yeast, plants, Drosophila) to genome-wide analyses of more complex phenomena including the three-dimensional organization of the genome, longevity, and neuronal function. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting on Enhancer Malfunction in Cancer, which will share a keynote address and two plenary sessions with this meeting.